Mechanisms of DNA and RNA Transactions

PROJECT SUMMARY: The goals of the research proposed for the MIRA renewal are: (i) to understand the
mechanisms and structures of enzymes that perform nucleic acid synthesis, modification, and repair; and (ii) to
elucidate factors that regulate these events. The project integrates diverse experimental approaches
(microbiology, biochemistry, structural biology, genetics) and applies them to model systems ranging from
viruses to bacteria to fungi. The principal themes are:
(1) The structures, mechanisms, and distinctive specificities of fungal tRNA splicing enzymes Trl1 (tRNA
ligase) and Tpt1 (tRNA 2'-phosphotransferase) – as paradigms of an RNA repair system essential for normal
cell physiology and as promising targets for anti-fungal drug discovery. We will determine structures of Trl1 and
Tpt1 in complexes with nucleic acid and nucleotide substrates and cofactors, and endeavor to capture
structural snapshots of intermediates and transition-states along the reaction pathways.
(2) The structural basis for RNA recognition and strand joining by ATP-dependent 5'-PO4/3'-OH RNA ligase T4
Rnl1. Rnl1 is a tRNA repair enzyme that the T4 bacteriophage uses to evade a tRNA-damaging host response
to virus infection.
(3) The unique catalytic mechanism, end-specificity, and regulation of GTP-dependent 3'-PO4/5'-OH RNA
ligase RtcB. The RtcB-family ligases are found in all phylogenetic domains. They are agents of diverse RNA
transactions, including tRNA splicing (in metazoa and archaea), RNA repair (in bacteria), nonspliceosomal
mRNA splicing (in the metazoan unfolded protein response), and the formation of chimeric RNAs in human
cells that can undergo retrotransposition into the human genome.
(4) Tandem transcriptional interference as a controlling factor in fission yeast phosphate homeostasis. The
three S. pombe PHO regulon genes are repressed in phosphate-replete cells by transcription in cis of 5’-
flanking lncRNAs that interferes with the PHO mRNA promoters. The lncRNA-mediated interference that
underlies the repression of pho1 has afforded us a sensitive read-out of genetic influences on 3'-
processing/termination and a powerful tool for discovery of agents and regulators of this step of the Pol2
transcription cycle. These influences include: (i) the Pol2 CTD code; (ii) numerous components of the 3'-
processing/termination machinery; and (iii) metabolite control by inositol pyrophosphate 1,5-IP8, an intracellular
signaling molecule. We propose to investigate the fission yeast Asp1 kinase/pyrophosphatase enzyme that
determines IP8 dynamics and the cellular proteins and pathways that connect IP8 to gene expression.

Public health relevance
RELEVANCE: The mechanistic and structural studies of diverse nucleic acid transactions proposed for the MIRA renewal have relevance for human physiology and pathophysiology insofar as: (i) tRNA splicing enzymes Trl1 and Tpt1 are promising drug discovery targets for treatment of fungal infections; (ii) RNA ligase RtcB is a central agent of the unfolded protein response to cellular stress; and (iii) metabolite control of RNA 3’- processing and transcription termination by inositol pyrophosphate 1,5-IP8 highlights a new level of gene regulation in eukarya.